Membrane Transporters: Critical Determinants For Aids Antiviral Drugs

HIV protease inhibitors, such as, ritonavir and saquinavir, are substrates for xenobiotic efflux pumps, e.g., P-glycoprotein and Mrp2 and thus penetrate the blood-brain barrier poorly. To map the extracellular and intracellular signals that regulate these transporters, we use 1) pharmacological tools, 2) intact brain capillaries from rats and mice (including transgenics and knockouts), 2) fluorescent substrates, 3) confocal imaging to measure transport function, 4) Western blotting to measure transporter expression, and 5) brain perfusion in rats and mice to validate signaling-based changes in blood-brain barrier transporter function in vivo. Our recent studies have focused on identifying signals that modify efflux pump activity at the barrier. One strategy for improving CNS delivery of drugs that are P-glycoprotein substrates involves activating protein kinase C (PKC) isoform beta1 or sphingolipid signaling at the blood-brain barrier. This causes a rapid and reversible reduction in basal P-glycoprotein transport activity in isolated brain capillaries and in intact rats. We have now identified a drug, Fingolimod (FTY720) currently in use in the clinic, that will target this signaling system and reduced P-glycoprotein tranport activity in vitro and in vivo. In vivo, such signaling increases brain uptake of drugs that are P-glycoprotein substrates. Thus, targeting signals that regulate basal activity of this transporter increases delivery of therapeutic drugs to the brain, including HIV protease inhibitors. These in vitro and in vivo experiments with animal models suggest a specific strategy for modifying this barrier to improve drug delivery, but also potentially important complications of polypharmacy related to xenobiotic upregulation of efflux transporter expression. A second project involves understanding in glial cells how the activity of efflux transporters and their handling of HIV protease inhibitors are affected by inflammation. Active HIV infection within the central nervous system (CNS) is confined primarily to microglia. The glial cell compartment acts as a viral reservoir behind the blood-brain barrier. It provides an additional roadblock to effective pharmacological treatment via expression of multiple drug efflux transporters, including P-glycoprotein. HIV/AIDS patients frequently suffer bacterial and viral co-infections, leading to deregulation of glial cell function and release of pro-inflammatory mediators including cytokines, chemokines, and nitric oxide. To better define the role of inflammation in decreased HIV drug accumulation into CNS targets, we measured accumulation of the antiretroviral saquinavir in purified cultures of rodent microglia exposed to the prototypical inflammatory mediator lipopolysaccharide (LPS). LPS did not directly inhibit saquinavir transport, and did not affect P-glycoprotein protein expression. LPS exposure did not alter RNA and/or protein expression of other transporters including multidrug resistance-associated protein 1 and several solute carrier uptake transporters. LPS exposure decreased saquinavir accumulation in microglia by a complex mechanism involving NF-κβ and the MEK1/2. These data provide new pharmacological insights into why microglia act as a difficult-to-treat viral sanctuary site.